Protein Phosphorylation Networks in Health and Disease

Summary
Kinases regulate normal physiological response to environmental perturbations. When dysregulated, either
through aberrant expression or mutation, protein kinases have been implicated in a host of diseases, from
developmental disorders to cancer. Accordingly, many of the successful targeted therapeutics for cancer and
developmental diseases have been generated against aberrantly activated kinases. Unfortunately, the
therapeutic efficacy of most of these agents has been largely disappointing due to the emergence of resistance
caused in part by rewiring of the signaling networks and by mutations that interfere with drug binding. In many
cases, mutant kinases cannot be efficiently inhibited due to our incomplete understanding of the effect that
disease mutations exert on kinase activation state, downstream network compensation, and anticipated
response to a drug. Understanding the normal physiological role of protein kinases and their phosphorylation
networks will significantly improve our ability to selectively target disease-associated kinases and will enable
the development of next-generation targeted combinatorial therapeutics with greatly increased efficacy. There
are three specific objectives of the FASEB 2023 Protein Phosphorylation Networks in Health and Disease
Conference. The first objective is to describe the state of the art in kinase structure, function, localization,
regulation, interactions, and targeting in both normal and pathological cell states. To accomplish this goal, we
have planned a series of keynote and plenary speakers from many of the leading experts in the field, multiple
short talks selected from the poster abstracts, poster sessions, several focused workshops, and informal
discussions. Since the challenges in this field are daunting and will require collaborative efforts to solve them,
the second goal is to enhance interactions between academia, industry, and clinical science and to enhance
interactions between research approaches, from biochemical-, structural-, systems-level, and computational
fields related to phosphorylation. To this end, we have specifically invited speakers representing each of these
topics, and are planning workshops on new techniques in the field. The third objective is to invest intellectually
and financially in the future by supporting promising young trainees, with an eye towards increasing diversity in
the field. The goal is to encourage trainees to be successful and stay in the field by providing intellectual
support through discussions with senior scientists, poster sessions, opportunities to speak, awards that
recognize their achievements, and by providing financial support with competitive travel awards. The expected
outcomes are increased collaborations, retention of young scientists in the field, identification of new
developmental processes and diseases linked to kinase signaling, and exploration of new state of the art
approaches for identifying and developing therapeutic targets and strategies to combat cancer, developmental
deficiencies, and other diseases.

Public health relevance
Project Narrative This application requests funding to provide partial support of a conference focused on the role of protein phosphorylation and protein kinases in normal biology and cancer. Efficacy of targeted therapeutics has been limited by resistance mechanisms driven by signaling network rewiring and mutations that often exert allosteric effects on drug binding pockets or alter signaling networks in a manner that allows for compensation. Participants at this conference will be exposed to the challenges of kinase-based therapeutics and be provided with ideas on how to address them, including: the newest experimental methods to study allosteric transitions in kinases that define specificity of drug binding and systems and mathematical approaches to studying networks in normal and diseased-states. Participants will be encouraged to incorporate these ideas, as well as new collaborative interactions, into their future research programs via the highly interactive program including workshops on cutting-edge technologies.